Deep-Learning-Augmented Quantitative Gradient Recalled Echo (DLA-qGRE) MRI for in vivo Clinical Evaluation of Brain Microstructural Neurodegeneration in Alzheimer Disease

Alzheimer Disease (AD) is one of the major health problems in the US and worldwide; it is a neurodegenerative
disorder that is characterized clinically by progressive dementia caused by pathological changes in brain tissue
preceding clinical symptoms by 15-20 years. Clinically-accessible methods are critically needed to screen for
early AD pathology and monitoring it over time, as well as for outcome measures in clinical drug trials.
The goal of this grant application is to establish an MRI-based technique, Deep-Learning-Augmented
quantitative Gradient Recalled Echo (DLA-qGRE), as a platform for quantitative clinical evaluation of brain tissue
microstructural neurodegeneration at early preclinical stages of Alzheimer Disease (AD). DLA-qGRE is a
combination of qGRE MRI technique and Regularization by Artifact REmoval (RARE) deep learning (DL)
methodology, both developed by our team. qGRE data obtained from a well-characterized cohort of patients
revealed the existence of brain regions with low R2t* values (Dark Matter), representing tissue essentially devoid
of neurons. These data show that Dark Matter can be identified already in people with preclinical stages of AD
(amyloid positive but without clinical symptoms) and also has a predictive power of future AD progression.
While qGRE sequence can be implemented on any commercial MRI scanner, the data analysis currently
requires hours of computing time, tempering clinical applications. To significantly accelerate and improve data
analysis, as well as data acquisition, in this proposal we will use innovative RARE technique, a DL approach that
explicitly accounts for the physical models of specific imaging systems and biophysical models of biological
tissues. Preliminary data show that DL has a potential for reconstructing qGRE metrics in a matter of seconds
with improved image quality and reduced noise. This opens opportunity for implementing DLA-qGRE as a widely
available tool for clinical applications. Based on this approach, we plan to achieve the following Specific Aims:
In Aim 1 we will develop DLA-qGRE data processing pipeline, compatible with MRI protocols of commercially
available GRE sequences, for fast and reliable detection of microstructural pre-atrophic neurodegeneration.
In Aim 2 we will optimize k-space sampling strategy for developing qGRE imaging protocol with increased
isotropic resolution and simultaneously decreased MRI acquisition time. Reducing scan time will significantly
help with patient comfort, be much less susceptible to motion, and reduce costs of the MRI exam.
In Aim 3 we will demonstrate that in a clinical neuroradiology setting DLA-qGRE compatible with MRI protocols
of commercially available GRE sequences (developed per Aim 1), and accelerated DLA-qGRE (developed per
Aim 2), can reliably detect microstructural neurodegeneration in preclinical and early symptomatic AD.
In Summary, successful completion of the aims of this proposal will open doors for using DLA-qGRE in clinical
settings as novel and more sensitive and specific MRI-based diagnostic measure of the neurodegenerative
aspects of early AD pathology as compared with current measurements of tissue atrophy.

Public health relevance
Alzheimer Disease (AD) is one of the largest health problems in the US and worldwide; it is a brain disease that is characterized by progressive dementia due to pathological changes in brain tissue that begin many years before clinical symptoms. The goal of this grant application is to establish an MRI-based technique, Deep- Learning-Augmented quantitative Gradient Recalled Echo (DLA-qGRE), as a platform for quantitative clinical evaluation of brain tissue microstructural neurodegeneration at early preclinical stages of Alzheimer Disease (AD), to identify people at highest risk for developing dementia when drug intervention could be most efficient. The overall impact of this project will be to set the stage for reducing the cost and complexity of MRI procedures, and increasing their sensitivity and specificity as diagnostic tests for Alzheimer disease and other neurodegenerative conditions.